Psychobiological regulation and molecular characterization of cell-free mitochondrial DNA in humans

PROJECT SUMMARY
Mitochondrial signal transduction is an emerging biological pathway linking adverse psychosocial exposures to
disease risk. However, we lack scalable, sensitive, and biologically meaningful markers to explore the role of
mitochondrial biology in the stress-disease cascade. We have identified blood cell-free mitochondrial DNA (cf-
mtDNA) as a stress-inducible marker, discovered the existence of cf-mtDNA in saliva, and developed a scalable
laboratory platform (MitoQuicLy) to quantify cf-mtDNA from thousands of samples in various biofluids. Building
on these discoveries, in Aim 1 we will deploy MitoQuicLy to profile cf-mtDNA dynamics across >5,800 blood and
saliva samples from three laboratory socio-evaluative stress studies. Building on the existing deep phenotyping
across these cohorts, these new measurements of cf-mtDNA dynamics, including built-in validation across
cohorts, will provide robust estimates of cf-mtDNA reactivity effect sizes, sex differences, baseline psychosocial
and mental health correlates including anxiety and depressive symptoms, and cortisol – a putative driver of cf-
mtDNA dynamics. Two studies include experimental or quasi-experimental manipulations of systemic energy
metabolism and mitochondrial health, providing an opportunity to examine the influence of mitochondrial
energetics on cf-mtDNA reactivity. In Aim 2, we will generate the first comprehensive human psychosocial stress
proteome using aptamer-based technology proteomics to quantify ~6,100 circulating proteins. With this dataset,
we will define when and how much known proteins increase, decrease, or are unchanged following socio-
evaluative stress, providing a high-resolution map of systemic molecular recalibrations. This will show how the
human brain-body system as a whole responds to acute mental stress, potentially providing new cues about the
interplay of metabolic, immune, endocrine, digestive, and other systems under stress. Using this exciting new
dataset, we will identify functionally relevant families of proteins i) that precede and statistically predict peak cf-
mtDNA reactivity, ii) that are co-released and follow the same quantitative dynamic trajectory as cf-mtDNA, and
iii) that follow the peak of cf-mtDNA reactivity and represent potential systemic consequences of cf-mtDNA
signaling. In Aim 3 we apply a combination of sensitive molecular and biochemical approaches to define the
molecular nature of cf-mtDNA in humans. Building on recent work demonstrating that cf-mtDNA does not
circulate as naked DNA fragments but rather as encapsulated cargo in extracellular vesicles, we will profile the
size, density, morphology, molecular composition, and functional characteristics of cf-mtDNA subtypes. To gain
further insight into the distinct forms of human cf-mtDNA, their potential origin, and functional physiological
significance in the stress-disease cascade, we will deploy these approaches to well-controlled baseline samples,
as well as post-stress samples at cf-mtDNA peak reactivity. These large-scale and molecular experiments will
generate foundational knowledge to develop new mitochondrial markers for stress and mental health research.

Public health relevance
PROJECT NARRATIVE The field of psychobiology lacks robust, biologically informative biomarkers to evaluate the emerging role of mitochondria in the stress-disease cascade. We have assembled an interdisciplinary team of psychosocial, clinical, and mitochondrial scientists to examine the psychobiological regulation of cell-free mitochondrial DNA (cf-mtDNA) and validate dynamic features of stress-evoked cf-mtDNA responses across thousands of samples from healthy women and men. The combined i) multi-study psychosocial challenge approach, including nested (quasi)experimental manipulations of mitochondrial energy metabolism, ii) novel discovery-based human stress proteome analyses, and iii) laboratory experiments to dissect the molecular nature of cf-mtDNA, will provide foundational knowledge to develop novel markers of mitochondrial biology, which can subsequently be deployed at scale in clinical and epidemiological studies aiming to understand the basis of human health, resilience, and vulnerability to disease.